Regulation of SCI-induced pain by macrophages and exercise

PROJECT SUMMARY
Spinal cord injury (SCI) impairs sensory transmission and leads to chronic, debilitating neuropathic
pain. Chronic pain afflicts over 100 million Americans and creates an enormous burden on US health care
systems, costing over half a trillion dollars annually according to a recent report from the Institute of Medicine.
While our understanding of the molecular basis underlying the development of chronic pain has improved, the
available therapeutics provide limited relief. While our lab and others have shown that early post-SCI rehab
can prevent pain development, early rehab in human SCI may not be possible due to the multisystem,
polytraumatic injuries individuals with SCI sustain. Thus, there is a critical need for an adjuvant therapy to aid
those individuals who are unable to participate in early rehab. Neuropathic pain is increasingly recognized as a
neuroimmune disorder. While macrophages are regarded as key regulators of chronic pain development, it is
unclear whether they are acting in an inflammatory or reparative manner. This R01 seeks to better understand
how or if the activation state of macrophages influences nociceptive neuron excitability and pain development
after SCI. We will utilize an established spinal cord injury model of neuropathic pain development and drive
macrophage activation state by post-injury rehab, intrathecal administration of exosomes derived from Raw
264.7 macrophages stimulated in vitro or a phosphodiesterase 4 inhibitor by a polymer nanodelivery system
that specifically targets macrophages. This proposal seeks to understand the role of macrophages that infiltrate
the dorsal root ganglia and persist there chronically after SCI both in the development and maintenance of
chronic neuropathic pain.

Public health relevance
PROJECT NARRATIVE Chronic pain is a debilitating consequence of spinal cord injury that is refractive to current treatments. This proposal aims to examine how the macrophage activation state can modulate nociceptor excitability, and if altering macrophage phenotype reduce the development of spinal cord injury-induced pain. Understanding these interactions will give us a better understanding of the underlying neuropathology that occurs early after a spinal cord injury in the dorsal root ganglia that leads to pain development or prevention.